Modulation of Pediatric Sepsis by Virus Persistence

Project Summary
Sepsis-induced multi-organ dysfunction syndrome (MODS) is a heterogeneous condition with distinct
phenotypes, including hypoactive immune response (“immunoparalysis”) and hyperinflammation. There
remains a significant unmet need for novel biomarkers that help to define sepsis phenotype and predict
responses to immunomodulatory therapy for patients with sepsis. Laboratory evidence of persistent viral
infection may be such a biomarker. Common DNA viruses, such as human cytomegalovirus, Epstein-Barr
virus, other human herpesviruses, and human adenoviruses, persist in their host following the resolution of
acute infection. Work from the proposed research team and others indicates that reactivation of persistent DNA
viruses has been linked to increased systemic inflammation and worse clinical outcomes in adults and children
with sepsis. The research team’s recently published work also suggests that virus persistence itself, even in
the absence of reactivation, can affect outcomes of sepsis in children. Additional published and preliminary
data from the Principal Investigator’s laboratory indicates that DNA virus persistence, again even in the
absence of reactivation, affects outcomes of subsequent challenges such as bacterial coinfection and bone
marrow transplantation. Immunomodulatory strategies are currently being evaluated for treatment of pediatric
patients with sepsis in the NIH-funded Personalized Immunomodulation in Sepsis-Induced MODS (PRECISE)
study, including immunostimulatory therapy with GM-CSF for immunoparalysis (GRACE-2; NCT05266001) and
anti-inflammatory therapy with anakinra administration for severe inflammation (TRIPS; NCT05267821). The
therapeutic potential of those immunomodulatory therapies may also be influenced by virus persistence,
particularly if they increase risk for virus reactivation. The overall hypothesis addressed by the research in the
proposed project is that persistent infection with one or more DNA viruses worsens clinical outcomes and
decreases response to immunomodulatory therapy in pediatric patients with sepsis. Aims 1 and 2 will test that
hypothesis using clinical data and biorepository samples from the PRECISE study, evaluating virus status by
detecting virus-specific antibody and viral DNAemia and determining whether virus status correlates with
sepsis phenotype, clinical outcomes, measures of inflammation (serum concentrations of pro-inflammatory
cytokines), and response to immunomodulatory therapy. Aim 3 will evaluate potential mechanisms underlying
those effects, such as epigenetic modifications affecting pro-inflammatory cytokine expression, in a mouse
model of persistent viral infection followed by Klebsiella pneumoniae sepsis. This approach to defining virus
status as a determinant of sepsis phenotype and outcomes will provide valuable insight into the pathogenesis
of sepsis and guidance for development of novel patient-targeted therapies.

Public health relevance
Project Narrative Factors influencing the phenotype and outcomes of sepsis in pediatric patients are incompletely understood. We will use patient samples and a complementary mouse model to evaluate contributions of virus persistence and reactivation to sepsis pathogenesis and outcomes. The results of our research will assist with efforts to tailor therapeutic approaches for sepsis on an individual patient basis.